SURVIVAL ANALYSES FOR BREAST CANCER TREATMENT PROCEDURES

Data collection and survival analyses for patients undergoing various breast cancer treatment procedures were performed using CDMAS. Treat- ment evaluation and identification of prognostic indicators are end-points.